Genetics, Genomics and Bioinformatics (Core B)

CORE B: Abstract The Genetics, Genomics, and Informatics Core focuses on the application of genome-level analyses in neuroscientific investigation, both at the sequence (genetic), and gene expression and epigenetic (genomics) levels. The explosion of next-generation sequencing-based methods has made advanced computational expertise and infrastructure needed for all sequencing- based applications. The proposed Core aims at providing support for basic and advanced genetics and genomics experiments in both patient cohorts for translational studies and experimental models for basic research. Modern genetic and genomic approaches, including epigenetics, rely on sequencing technology and require substantial bioinformatics expertise and access to solid computational resources. This core leverages a proven history of expertise, as well as support and collaboration with other investigators in the Coppola and Geschwind groups with regards to computational and informatics resources funded by NIH and private foundations. Based on this proven track record, Core E will provide IDDRC investigators with the necessary expertise and infrastructure to perform high-throughput, genome-wide genetic and genomic studies. State-of- the-art analytical methods being developed within the NINDS-funded UCLA Informatics Center for Neurogenetics and Neurogenomics (ICNN, co-directed by Dr. Coppola) will be used to analyze NGS, gene expression, and methylation data, and the resulting datasets will be posted onto a database accessible to IDDRC investigators, facilitating data sharing and collaborative analyses. Over the past 10 years UCLA computational biologists and statisticians have lead the field of integrative data analysis (Geschwind and Konopka, 2009) and network-based methods [Zhang and Horvath 2005; Oldham et al. 2008; Parikshak et al. 2013]. Expertise in the development and implementation of these methods (including single-cell analysis, network methods, and integrative approaches), will be made directly available to IDDRC investigators.